Strengthening Bonds: A Telephone Reminiscence Intervention to Reduce Social Isolation and Improve Mental Health in Rural Older Adults

ABSTRACT
Older adults in rural regions face a “health penalty” compared to those in urban settings, experiencing poorer
mental health outcomes and higher rates of physical health problems. In addition, social isolation and
loneliness are significant concerns in rural regions. Evidence supports that social isolation and loneliness
negatively impact both the physical and mental health of older adults. Therefore, it is essential to develop
targeted interventions that promote social connection and support healthy aging, aligning with the NIA’s Health
Disparity framework. Storii is an innovative telephone-based service that facilitates reminiscence, which serves
the purpose of recalling and sharing memories. Storii conducts reminiscence by posing meaningful questions
about participants’ life experience and collecting their responses directly over phone calls. This service helps
older adults create lasting memories while fostering stronger social connections with their informal caregivers.
Storii’s telephone-based service departs from traditional models that rely on in-person sessions or internet-
based platforms, creating a new paradigm for accessible mental health support. Storii leverages landline and
mobile phone technology to make reminiscence programs accessible to a broader audience, including those in
rural areas with limited digital infrastructure.
The direct to Phase II application proposes a clinical trial to enhance the Storii telephone reminiscence
program, focusing on increasing its accessibility and usability for older adults and informal caregivers living in
rural areas. The first specific aim is to increase Storii phone service accessibility by developing enhancements
to the existing Storii phone product and conducting focus groups and telephone surveys with 15 dyads (user
and informal caregiver). The second specific aim is to conduct a full-scale fidelity trial of the enhanced Storii
product with 300 dyads of older adults and informal caregivers living in rural counties. Successful completion of
this Phase II SBIR grant will demonstrate Storii’s potential as a scalable and accessible intervention for rural
populations. This program has the potential to significantly improve mental health outcomes and social
connections for older adults and their caregivers, especially those who have lacked opportunities to document
and share their life stories due to geographic or technological barriers.

Public health relevance
Storii, a telephone-based reminiscence platform, is in the process of being commercialized to address the significant risks of loneliness and isolation faced by 10.6 million older adults in rural areas by providing evidence-based reminiscence therapy without requiring internet or smartphone access. This SBIR project will enhance Storii’s AI functionality to enable fully voice-driven calls, eliminating the need for keypad inputs, and allow participants to listen to their recorded responses, which are refined and restructured into their own voice using AI. These advancements will create a scalable solution tailored to rural populations, improving mental health outcomes, reducing loneliness, and transforming support for older adults in geographically isolated communities.